Automated Dental Fracture Detection using High Resolution CBCT and Advanced Image Analysis

PROJECT SUMMARY
Epidemiological studies indicate that cracked teeth are the third most common cause of tooth loss in
industrialized countries. Histological studies demonstrate that all cracks are colonized by bacteria, which have
the potential to cause intensely painful pulpal and periapical infections. The early detection of cracks (incomplete
fractures) followed by appropriate interventions to prevent crack propagation are effective strategies to prevent
infections and avert tooth loss. Current tools used to diagnose cracks are inadequate and there is an imperative
need to develop an objective and reliable method to detect cracks. During our Phase I project, we developed
and tested a novel algorithm for crack detection on extracted human teeth. Using machine learning and imaging
features extracted from three-dimensional (3D) wavelets, we demonstrated enhanced crack detection hr-CBCT.
We now propose to further refine this technology and to validate it clinically. Our hypothesis is that our method
increases the predictive validity of hr-CBCT in detecting cracks. This development will happen with close clinical
guidance. Also, we will collaborate with CBCT hardware vendors to increase the impact of our commercialization
plan. This proposal addresses the need for quantitative, reproducible, and evidence-based ways to detect
cracks in teeth, that can potentially lead to improved tooth loss prevention.

Public health relevance
PROJECT NARRATIVE Cracked teeth are a common cause of tooth loss in industrialized countries. Histological studies demonstrate that all cracks are colonized by bacteria, which have the potential to cause painful pulpal and periapical infections. The early detection of cracks followed by appropriate interventions are effective strategies to prevent infections and avert tooth loss. Current tools used to diagnose cracks are inadequate and there is an imperative need to develop an objective and reliable method to detect cracks. This Phase II proposal will refine the pilot algorithm for crack detection we developed during Phase I, and it will validate it clinically. This proposal addresses the need for quantitative, reproducible, and evidence-based ways to detect cracks in teeth, that can potentially prevent tooth loss.